HIV RISK IN LATIN MEN WHO HAVE SEX WITH MEN

DESCRIPTION (Adapted from the Applicant's Abstract): The purpose of this descriptive study is to generate preliminary findings for a subsequent intervention project. Participants will be a sample of 120 Latino men (40 Puerto Ricans, 40 Dominicans, and 40 other Latin Americans) who have had sex with other men. The goals are (1) to assess the men's knowledge of HIV disease and its prevention; (2) to explore prevalence and type of HIV-related sexual risk behavior; (3) to assess the extent and types of sexual dysfunctions these men may experience and whether dysfunctions hinder condom use; (4) to identify the labels these men use to describe their sexual orientation; (5) to assess internalized and perceived social homophobia; and (6) to compare the three groups of Latinos and explore the association of ethnicity, race, and acculturation with the other variables under study. Target participants will be between 18 and 60 years of age. They must have had sex with other men at least ten times in their lives. Participants will be assessed by means of a survey adapted from the AIDS Knowledge Scale of the 1988 National Health Interview Survey, a psychosexual interview, a homophobia interview, and Marin's Short Acculturation Scale, plus a semi-structured qualitative interview.